Contract Orientation and Kickoff Meeting

The objective of the “Preclinical PREVENT Cancer Program: Toxicology and Pharmacology Testing” IDIQ contracts will be to continue evaluation of the pharmacological and toxicological effects of potential cancer preventative agents. Resources from these contracts will be used to support development of several candidate cancer preventive agents.